GENETIC ANALYSIS OF MIGRAINE HEADACHE

This study will attempt to determine (i.e., map) the chromosomal location of the gene(s) responsible for the genetic susceptibility to migraine headaches using genetic analysis of 10-25 multi-generational families (100-300 subjects) that contain multiple members with migraine headache. International Headache Society criteria will be used to determine family members affected/unaffected by migraine. Linkage analysis will be performed by standard techniques of the core lab of Dr. Richard King on blood samples drawn from subjects.